The role of IL-17 in obesity-associated prostate cancer progression

About 35.5% American men are obese and obesity has been positively associated with high-grade prostate
cancer, castration-resistant prostate cancer, and prostate cancer-specific mortality. Obesity has been
associated with a 50% increased risk of pathological progression in prostate cancer patients under active
surveillance. However, the molecular mechanisms underlying the association between obesity and prostate
cancer progression remain as a significant knowledge gap to be filled. It is known that obese people often
develop type 2 diabetes (T2D) with increased blood levels of insulin and inflammatory cytokines such as
interleukin-17 (IL-17). We have previously demonstrated that IL-17 promotes development of hormone-naïve
and castration-resistant prostate cancer in Pten-null mice. Our preliminary studies found that prostate cancer
formation rate was increased by approximately 82% in high-fat diet-induced obese Pten-null mice compared to
lean Pten-null mice. We have demonstrated that insulin enhances IL-17-induced gene expression through
inhibition of glycogen synthase kinase 3 (GSK3). Moreover, we have originally found that GSK3 binds to and
phosphorylates IL-17 receptor A (IL-17RA) at residue T780, leading to ubiquitination and proteasome-mediated
degradation of IL-17RA. In obese mice, hyperinsulinemia activated phosphoinositide 3-kinase (PI3K)/Akt to
phosphorylate GSK3α at S21 and GSK3β at S9, thus inhibiting GSK3 activity; subsequently, IL-17RA
phosphorylation by GSK3 is reduced, resulting in increased levels of IL-17RA protein, followed by enhanced
IL-17 signaling and increased expression of multiple IL-17 downstream genes. These findings suggest that IL-
17 signaling and insulin signaling crosstalk via GSK3, which is a novel mechanism by which obesity drives
prostate cancer progression. Based on these findings, we have formulated a central hypothesis that GSK3 is
an intrinsic inhibitor of IL-17 signaling, and in obesity with T2D, high levels of insulin enhance IL-17-mediated
responses through inhibiting GSK3 activities, thereby promoting prostate cancer progression. We propose to
test our central hypothesis through achieving the following three specific aims: Aim 1) Determine GSK3’s role
in regulating IL-17’s pro-tumor function in Pten-null obese mice. We will use two animal models: a) we will
create Gsk3α;Pten and Gsk3β;Pten double knockout mice with wild-type IL-17ra; we expect to find a decrease
in IL-17RA phosphorylation by GSK3, a decrease in IL-17RA degradation, and an increase in IL-17-mediated
inflammation in mouse prostate, resulting in an increase in prostate cancer incidence; b) we will create IL-17ra
T779A knockin mutant (IL-17raKI/KI) mice that will not respond to GSK3-mediated phosphorylation of IL-17RA,
thus allowing assessment of IL-17-independent functions of GSK3; mouse T779 is homologous to human T780
on IL-17RA; we expect to find no significant differences in prostate cancer formation comparing Gsk3α;Pten
and Gsk3β;Pten double knockout mice with Gsk3 wild-type Pten-null mice with IL-17RA T779A mutation. Aim
2) Define the molecular mechanisms by which GSK3 inhibits IL-17 signaling. We will determine if IL-17RA
phosphorylation at T780 by GSK3 requires a primed phosphorylation and if there are other GSK3
phosphorylation sites on IL-17RA. Aim 3) Assess the association between GSK3/IL-17 status and prostate
cancer in obese/diabetic men. We will assess GSK3/IL-17 status in 500 prostate cancer specimens from
patients with normal body weight, overweight, and obesity, with or without T2D; we will assess the associations
between GSK3/IL-17 status and the clinical variables. Successful completion of the proposed studies will
provide novel molecular mechanisms of how obesity drives prostate cancer progression, which will significantly
advance the knowledge and reveal new targets in the prevention and treatment of prostate cancer.

Public health relevance
American Cancer Society estimates that there will be 161,360 new cases and 26,730 patients will die of prostate cancer in the U.S. in 2017. Prostate cancer is the most common malignancy and the third most common cause of cancer-related deaths in the U.S. men. It is estimated that one of six men will develop prostate cancer in their life-time. It was reported that in 2007, about 39,505 of Veterans were diagnosed with cancer. Among these 39,505 cancer diagnoses, 97.5% (38,513 cases) occurred in men, while 33% (12,543 cases) of Veterans men with cancers is prostate cancer – the most common cancer among Veterans men. These numbers clearly indicate that the proposed research on prostate cancer is highly relevant to the Veterans’ health and health care. Upon completion of the proposed research, we will provide novel molecular mechanisms of how obesity drives prostate cancer progression, which will significantly advance the knowledge and reveal new targets in the prevention and treatment of prostate cancer patients including Veterans.